Computational algorithm to predict interacting MHC alleles from TCR sequences

Abstract
Major histocompatibility complexes (MHC) guide immune response by presenting antigen
fragments on a cell’s surface and interacting with T-cell receptors (TCRs). In recent years, many
T-cell therapies have successfully engineered T-cells to target MHC-antigen complexes
associated with cancers and other diseases. However, most T-cell therapies require identifying
a TCR that interacts with an MHC-antigen complex of interest, a slow and expensive search
process. Our proposal aims to speed up this search process through a computational algorithm
that will predict whether a TCR will interact with an MHC allele of interest. Current screening
assays for low frequency TCRs have high false positive rates. Researchers can use our tool to
computationally filter TCR candidates for interaction with a specific MHC allele before running
expensive validation experiments. In this proposal, we will first validate our approach through a
prototype algorithm that we will train on public TCR-MHC interaction data. We will then conduct
new tetramer staining experiments that address two major challenges for developing an
algorithm across multiple MHC alleles: the lack of interaction data for alleles other than A*02,
and the limited antigen diversity in existing public data. These experiments will provide
TCR-MHC data across 800 antigens for four common MHC alleles: A*01:01, A*02:01, A*11:01,
and B*07:02. Finally, we will construct and validate computational algorithms for each MHC
allele and evaluate the importance of various TCR components (e.g., alpha or beta chan,
CDR3) in predicting TCR-MHC interaction. Our work will result in the first computational tool to
help T-cell therapy developers filter TCR candidates based on MHC specificity. Beyond cell
therapies, this tool will also help researchers track T-cells in diseases where MHC alleles play a
major role.

Public health relevance
Narrative We are developing a machine learning algorithm to identify T-cell receptors that interact with MHC alleles of interest. T-cell therapies show enormous promise for late stage cancer patients as well as millions of patients with resistant autoimmune conditions, but the T-cell identification process for developing a new therapy often takes years and costs millions of dollars. Our tool can significantly speed up this process by filtering out T-cell receptor candidates that do not interact with an MHC allele of interest.